Predoctoral Research Training in Statistical Genetics

DESCRIPTION (provided by applicant): The statistical genetics faculty at the University of Washington propose renewal of the predoctoral training program in biostatistics that emphasizes applications to genetics. The faculty members belong to the very strong departments of Biostatistics, Genome Sciences or Statistics at the University of Washington. The trainees will pursue Ph.D. degrees in one of the three departments. The training program will include the current Ph.D. tracks in statistical genetics offered by the Departments of Biostatistics and Statistics but it will have the additional feature of rotations in experimental laboratories and opportunities for internships in local companies. In addition to formal courses taught by international experts in statistical genetics, the training program features journal club, seminars and retreats. Trainees will also be able to attend modules in the annual Summer Institute in Statistical Genetics held at the University of Washington.

Public health relevance
Biology in general and genetics in particular, is becoming increasingly quantitative. Many major advances in medical science are being made possible by the massive amounts of data from the Human Genome Project, the HapMap project, the 1000 Genomes project and related activities. Managing and interpreting these data requires the development and application of new statistical methodologies. This training grant will support highly talented students in the Departments of Biostatistics, Genome Sciences or Statistics and ensure that they are trained to lead such development and application.